Data Analysis Core

Project Summary The VU-BIOMIC Data Analysis Core (DAC) is tasked with both pre-analytical and analytical challenges. The investigators of the DAC have broad range of experience working with high-dimensional imaging mass spectrometry data sets, even leading the field in new methodologies to process such data. In addition, the DAC team has pioneered methods to combine high spatial resolution microscopy and 3-dimensional data sets with IMS. However, BIOMIC will require that the DAC architect a platform that integrate all of the pre-analytical and analytical computational approaches into a complete computational platform capable of processing the data generated by the Characterization pipeline efficiently. A primary driving force behind all work carried out will be automation of the reconstruction and subsequent analysis. This will allow plug-and-play analysis of new datasets as they are generated. As the experimental workflow is expansive, it is important that the DAC provide rapid feedback of metrics to track data quality and provide analyses that lead to biological insight.

Public health relevance
PROJECT NARRATIVE – Data Analysis Core This application proposes the founding of the BIOmolecular Multimodal Imaging Center (BIOMIC) at Vanderbilt University, a Tissue Mapping Center associated with the Human BioMolecular Atlas Program (HuBMAP). The mission of BIOMIC is to build a platform of integrated technologies for imaging and molecular analysis that enables the construction of comprehensive 3-dimensional molecular atlases of human tissues. The goal of the BIOMIC Data Analysis Core is to develop the computational resources necessary to construct, visualize, and mine 3-dimensional multimodal molecular imaging data by leveraging an already successful collaborative team at Vanderbilt University and Delft University of Technology.